The Impact of SLC26A9 on Response to CFTR Correction

PROJECT ABSTRACT / SUMMARY
Although CFTR modulator therapies have improved respiratory outcomes for the Cystic Fibrosis (CF) population,
the benefit to individual patients can vary widely. In “real world” studies of modulator therapies, patients continue
to experience lung function decline, and as many as 1 in 5 receive no therapeutic benefit in FEV1. The factors
that determine who has a strong or poor therapeutic response are not well defined, and limit both the current
benefit from modulator drugs and future benefit from gene therapies. One proposed but poorly understood factor
is the solute carrier SLC26A9, and specifically the risk locus rs7512462 within that gene. This locus is associated
with extrapulmonary disease severity in CF, and appears to be linked to CFTR modulator response, though the
mechanism of this association and its future impact on CF gene therapy remains unclear.
Our long-term goal is to create personalized medicine strategies to optimize care while reducing disparities in
disease burden for individuals with airway disorders. The overarching goal of this project is to identify the cellular
mechanism and real-world impact of SNP rs7512462 in SLC26A9 on modulator response, and to understand
the impact of this interaction on future CFTR-focused therapies. Our central hypothesis for this work is that
rs7512462 influences SLC26A9 expression, which is a major determinant of lung function response to
modulators via modification of airway ion/fluid homeostasis.
We will address this hypothesis through two aims. First, we will recruit individuals with CF and above- or below-
average response to modulators based on rate of lung function decline. We will evaluate the relative impact of
SLC26A9 genotype on lung function decline in this cohort, and the physiologic impact on the respiratory
epithelium using patient-specific ex vivo airway culture. Second, we will determine the mechanism of this
interaction through in vitro studies utilizing isogenic cell lines co-expressing risk and protective alleles at
rs7512462 with key CFTR variants. We will determine the impact of SLC26A9 genotype on CFTR rescue by
modulators and by CFTR gene replacement therapy using an AAV-CFTR construct. We will also assess
SLC26A9 as a potential therapy, delivering this gene construct in a similar AAV vector and quantifying its impact
on airway epithelial physiology.
Through these studies, we will identify the magnitude, mechanism, and real-world relevance of SLC26A9’s
influence on patient-specific disease variance, as well as generate proof-of-concept of SLC26A9 as a therapeutic
agent. This approach will lead to novel targets to stratify risk and optimize care at the individual level, facilitating
precision care in muco-obstructive lung diseases impacted by SLC26A9, including CF.

Public health relevance
PROJECT NARRATIVE The proposed work is highly relevant to public health because it will determine the mechanism and magnitude of impact of rs 7512462 in SLC26A9 on personalized response to CFTR modulator drugs and gene therapy. This is relevant today, as these effects limit an individual’s response to potentially disease-modifying drugs, and will remain relevant in the future, as such an effect may confound small studies of gene therapy and limit the benefit of such treatments. These studies are also relevant beyond cystic fibrosis, as studies have identified a role of SLC26A9 in other muco-obstructive lung diseases including bronchiectasis and COPD.